Health Promotion and Disease Prevention Research Center

ABSTRACT
Despite the growing number of evidence-based cancer prevention and control interventions and strategies to
reduce the burden of cancer, most are not well adopted in local communities. The Emory CPCRN will increase
the translation of cancer and HPV vaccine evidence into local communities. Wider use of effective
interventions can significantly reduce cancer morbidity and mortality. The Emory CPCRN has 6 inter-related
aims and will: Aim 1. Maintain and strengthen the Emory CPCRN infrastructure to support and enhance
capacity-building for cancer prevention and control and implementation science research and practice at
Emory and in rural communities across Georgia; Aim 2. Cultivate and strengthen partnerships with
communities, public health agencies, community-based organizations, and cancer control research and
practice networks to promote community-based participatory approaches to preventing cancer and reducing
health disparities; Aim 3. Conduct national and local trainings to build capacity on adoption and implementation
of evidence-based approaches in collaboration with our Southwest GA partners and regional cancer coalitions;
Aim 4. Assess factors related to HPV vaccination using the P3 (Practice, Provider, and Patient-Level) model to
inform intervention development through a qualitative study in Southwest Georgia; Aim 5a. Evaluate a multi-
level intervention employing implementation strategies of mini-grants and technical assistance on HPV vaccine
series initiation and completion among clinical and community organizations in SW Georgia; 5b. Assess
implementation outcomes and factors related to implementation success using the Consolidated Framework
for Implementation Research (CFIR) through a mixed-methods study; and Aim 6. Disseminate and translate
research findings to local, regional and national cancer control researchers and practitioners. The Emory
CPCRN proposed aims will enhance the capacity of clinical and community organizations in Southwest
Georgia and the state through training, research and dissemination efforts. We will contribute a model for
testing intervention strategies for clinical and community organizations to adopt evidence-based interventions
for increasing HPV vaccination rates.

Public health relevance
NARRATIVE Despite the growing number of evidence-based cancer prevention and control interventions and strategies to reduce the burden of cancer, most are not well adopted in local communities. The Emory CPCRN will increase the translation of cancer and HPV vaccine evidence into local communities. Wider use of effective interventions can significantly reduce cancer morbidity and mortality.